HOPE Training Grant

PROJECT SUMMARY/ABSTRACT
The sustained global impact of the viral pandemics of HIV and SARS-CoV-2 and the challenges to the
management and prevention of disease require the training and development of talented new researchers.
Since 1990, we trained postdoctoral scholars in this program at the University of California, San Diego (UCSD).
The program is designed to produce new investigators who are capable of independently leading impactful
research in basic and translational viral biology and pathogenesis. This application proposes renewal of this
highly successful training program. Based on our strategic planning process, we propose an expansion in the
program’s scope to better reflect the research priorities of the Office of AIDS Research and to respond to the
challenges of viral pandemics like COVID-19. Specifically, the program’s priorities will include reducing incidence
(including vaccination), therapeutics and cure, health disparities, and long-term comorbidities. To reflect this
expansion, we propose a new leadership structure, have grown our faculty to 23 mentors who have an extensive
history of independent research, collaborations, and training. We have renamed the application to reflect these
changes, HIV and Other PandEmics, or HOPE. We have also added 10 mentors-in-development (MiDs), who
are an internal talent pool from which a new generation of mid-career mentors for the HOPE Training Program
will develop over time. The faculty are committed to identifying talented and committed postdoctoral trainees and
to providing the environment and opportunities that will support their path to independence in medically relevant
basic, translational, clinical, and epidemiological research.
The program will retain its successful educational and training elements, while incorporating innovative new
offerings to address one of the greatest challenges facing modern medicine and public health, SARS-CoV-2.
The research interests and activities of our faculty support the evolving focus and priorities of virology research
in general and specifically within our program. We propose to support six postdoctoral trainees for a training
period of two to three years each. We aim to continue to improve on our success in training underrepresented
minorities and women. Through our program of closely mentored, trainee-driven research, interactive research
review, and career development activities, our overarching goal remains to prepare the next generation of
scientists for highly productive careers in biomedical research with local, national and international impact.

Public health relevance
PROJECT NARRATIVE HIV and other viral pandemics, including COVID-19, present substantial challenges to public health. The field needs new, talented investigators who can bring innovative solutions to address these continuing crises, a need that will be directly addressed by renewal of our highly successful, postdoctoral training program. The program now incorporates SARS-CoV-2 research, improves trainee productivity, and enhances recruitment of women and underrepresented minorities, with the objective of advancing early-stage investigators to independence so that they can address the continuing challenges of the HIV and other pandemics.